Pathology Shared Resource

PROJECT SUMMARY: PATHOLOGY SHARED RESOURCE
Together, the Tissue Sciences Facility (TSF) and Tissue Procurement Shared Resource (TPSR) make up the
Pathology Core Facility, which was created to provide comprehensive tissue banking, histology, imaging and
related instrumentation and expertise to members of the Fred and Pamela Buffett Cancer Center (BCC)
investigators. The Tissue Sciences Facility (TSF) was created to provide comprehensive histology and imaging
applications to Fred and Pamela Buffett Cancer Center (BCC) investigators. The Tissue Procurement Shared
Resource (TPSR), also part of the Pathology Core Facility, was created to provide frozen and rapid autopsy
samples to members of the Buffett Cancer Center. The availability of expert advice and services to both new
and established investigators, including routine histology, paraffin and frozen sectioning, histochemical
staining, routine and multiplex immunohistochemistry, in situ hybridization, digital imaging, project
customization, and pathology consultation, are emphasized in the facility. These services provided by highly
trained laboratory scientists offer comprehensive pathology support for basic science and translational
research. Collaboration and pathological consultation are available to BCC investigators at all points in the
research process by Pathology faculty.